Optimizing respiratory plasticity with chronic cervical SCI

ABSTRACT
Cervical spinal cord injury (cSCI) disrupts neural pathways to spinal respiratory motor neurons, causing
respiratory impairment and even death. New treatment strategies are desperately needed to improve breathing
ability after cSCI. Since most cSCI are incomplete, meaningful functional recovery can be induced by harnessing
the intrinsic capacity for neuroplasticity, strengthening spared neural pathways to respiratory motor neurons.
Repetitive acute intermittent hypoxia (rAIH) is a simple, safe and effective means to induce respiratory motor
plasticity and improve breathing ability in rodent models of acute cSCI. Unfortunately, moderate rAIH is less
effective with chronic cSCI. Thus, unknown factors associated with chronic (not acute) cSCI undermine rAIH
efficacy. Candidates include cross-talk inhibition from competing mechanisms of adenosine-dependent plasticity,
persistent neuroinflammation and age-dependent sexual dimorphisms. In this project, our fundamental goals
are: 1) to understand factors limiting AIH-induced phrenic motor plasticity; and 2) use that understanding
to develop refined rAIH protocols that optimize therapeutic efficacy with chronic cSCI.
AIH elicits multiple distinct mechanisms of phrenic motor facilitation (pMF), including: 1) serotonin-dependent
Q pathway initiated by carotid chemoreceptor activation; and 2) adenosine-dependent S pathway initiated by
local hypoxia in the phrenic motor nucleus. Although each pathway has therapeutic potential if activated alone,
co-activation leads to pathway competition and even pMF cancellation. We hypothesize that chronic cSCI shifts
the balance towards equal Q & S pathway activation, undermining rAIH therapeutic efficacy. Minimizing spinal
hypoxia and adenosine accumulation by shortening AIH hypoxic episodes is predicted to improve functional
outcomes by removing the adenosine constraint to plasticity. Since inflammation undermines serotonin (not
adenosine)-dependent pMF, we will also test the hypothesis that anti-inflammatory drugs improve rAIH efficacy
with chronic cSCI. Finally, since AIH-induced phrenic motor plasticity exhibits profound age-dependent sexual
dimorphisms, we will compare rAIH efficacy in middle-aged male vs female rats. By using two established models
of chronic (> 8 weeks) cSCI (C2 hemisection and C4 spinal contusion), we anticipate more robust conclusions
since each model has unique advantages/limitations. Five aims are proposed to test the hypotheses that: 1)
cSCI decreases spinal PO2, increasing the adenosine constraint to pMF; 2) AIH with shorter hypoxic episodes
lessens tissue hypoxia and adenosine accumulation, optimizing pMF; 3) in male rats, optimized rAIH improves
breathing capacity more than “conventional” rAIH; 4) anti-inflammatory drugs enhance rAIH efficacy; and 5)
optimized rAIH improves breathing capacity more in middle-aged female versus male rats. Each aim is supported
by exciting preliminary data demonstrating feasibility and proof of concept. By optimizing repetitive AIH-
induced plasticity to improve breathing ability, we gain new mechanistic insights and move closer to
comprehensive clinical trials in humans suffering from impaired breathing due to chronic cSCI.

Public health relevance
PROJECT NARRATIVE Repetitive exposure to acute intermittent hypoxia (rAIH) restores breathing ability in rodent models of acute spinal cord injury, but is less effective with chronic injuries. Our fundamental goal is to understand mechanisms limiting rAIH efficacy in rats with chronic cervical spinal cord injuries. Increased understanding will inform our efforts to optimize rAIH protocols for use in planned clinical trials in people suffering from impaired breathing due to chronic cervical spinal injury.